Center for Improving Care Delivery for the Aging (CICADA)

Project Summary – Leadership and Administrative Core
This proposed renewal of the Resource Center for Minority Aging Research (RCMAR) at the University of
Pennsylvania (Penn)—the Center for Improving Care Delivery for the Aging (CICADA)—aims to train emerging
scientists from minoritized and underrepresented backgrounds in the interdisciplinary science of equity-
integrated health services research (HSR), an interdisciplinary scientific field focused on improving
organization, management, financing, and delivery of high-quality care and improving health equity. Over the
initial funding cycle, CICADA’s Leadership and Administrative Core (LAC) has united and led a diverse
team of experts to achieve the Center’s overall aims: (1) to enhance the diversity of the aging-focused
research workforce by mentoring promising scientists from underrepresented and minoritized groups for
careers dedicated to improving health care delivery and health equity for older adults and (2) to develop and
sustain infrastructure to promote science that improves the health, wellbeing, function, and independence of
older adults—particularly minoritized older adults—through transformation in health care delivery, with the goal
of achieving health equity.
To accomplish this, the LAC will continue to oversee the Center’s Research Education Component (REC) and
Analysis Core, and to ensure that we achieve the Specific Aims of each core. The LAC will work closely with
the leaders of these three components (CICADA’s “core faculty”), who comprise the Center’s Executive
Committee, to ensure success. The LAC will also continue to work in close partnership with Penn’s institutional
partners (through the Internal Advisory Board), and with national experts in aging and equity-integrated HSR
(through the External Advisory Board). These groups will meet regularly with CICADA leadership and provide
guidance and evaluation of progress toward meeting the overall Aims of the Center. The LAC will also leverage
the resources of Penn’s Leonard Davis Institute of Health Economics to ensure CICADA’s success.
In this renewal application, the LAC will build on our prior successes and establish and build on an existing
strong relationship between Penn and Meharry Medical College, an Historically Black College and University.
With Meharry as an affiliated institution and partner, the LAC will oversee CICADA as it takes an equity-first
approach to recruiting and selecting a diverse and talented group of scientists and then training and mentoring
them during their time with CICADA and beyond, so that they may become future leaders in equity-integrated
HSR focused on aging. The LAC has three Specific Aims (1) To advance CICADA’s goals by overseeing,
managing, and coordinating Center activities; (2) To provide leadership to advance discoveries in equity-
integrated HSR at Penn, focused on improving health care delivery and health for aging adults; (3) To foster
and integrate diversity, equity, inclusion, and accessibility (DEIA) into all aspects of the CICADA environment,
taking an “equity-first” approach to Scientist mentoring and development.